Cancer and Leukemia Group B

DESCRIPTION (provided by applicant): The Dana-Farber Cancer Institute (DFCI) and Dana-Farber/Partners CancerCare (DF/PCC) proposes to use its membership in the Cancer and Leukemia Group B (CALGB) to support participation in therapeutic research and other clinical trials, both in the Institute and its affiliate institutions. The goals of this project will be the initiation and participation in Phase I, II and III cooperative clinical trials involving chemotherapy, surgery and radiation therapy. A major emphasis will be made in developing new therapeutic strategies both at DFCI, MGH and in pilot collaborative investigations with interested members of CALGB. Dana-Farber investigators would continue to be actively involved in disease and modality committees of the CALGB. This project is designed to bring cooperative group trials to regional community hospitals affilaited through the Dana-Farber Cancer Institute throughout New England.

Public health relevance
RELEVANCE (See instructions): With this application we propose to continue the collaborative DF/PCC efforts within CALGB and continue to make significant contributions to advancing oncology clinical research. We intend to continue the tradition set forth in Dana-Farber's previous grants of piloting studies in-house and subsequently bringing tested concepts to the Group for consideration as CALGB Phase II and III trials.